Investigator Development Core

PROJECT SUMMARY – INVESTIGATOR DEVELOPMENT CORE
Eliminating health disparities in Arkansas is particularly challenging, since rural and Black/African American
populations are disproportionately affected by the burden of chronic disease. As part of strategic plans to
address the problem, a diverse and productive workforce is needed to conduct research that mitigates health
disparities and supports health equity. Supporting early stage investigators provides an effective and productive
solution in workforce development, when structured plans are provided for investigators who come from health
disparity and underrepresented groups. The overarching goal of the Investigator Development Core is to reduce
inequities in the number of historically underrepresented researchers prepared to eliminate cancer and
cardiovascular disease health disparities by building a strong evidence-based training and mentoring
infrastructure that enhances skills and competencies of investigators to successfully compete for pilot project
funding, and subsequently secure National Institutes of Health research grants. The Core will apply social justice
principles and the National Institute on Minority Health and Health Disparities Research Framework to address
individual, interpersonal, and institutional structural factors that influence the diversity in the research workforce,
underrepresented researcher access to grant awards, equity in training and mentoring, participation in research
with community partners, and ultimately, increase the number of research studies that focus on eliminating
chronic disease disparities among groups often denied the human right to health. The Investigator Development
Core will use a mixed-methods approach (concept mapping, individual assessments pre-application) to capture
relevant data to assist the team in developing relevant training and mentoring components pre/post award. The
community liaison for the Training Mentoring Advisory Board will review grants for their impact on health equity
prior to submission and work with the Community Engagement Core to link community partners and pilot study
investigators. Finally, the Investigator Development Core will build on the National Mentoring Research Network
model to increase participation in the pilot grant program by addressing inequities in readiness to submit research
grants, using one-on-one consults, providing grant coaching and writing group support, and conducting team-
oriented mentoring to guide investigators from idea conceptualization to subsequent submission of an NIH grant
application. The expected impact will be increased recruitment, retention and professional advancement of early
stage investigators in conducting chronic disease health disparities research that informs future research, health
policy, and programmatic responses to eliminate health disparities.